Modern and secure freezing, storage, and distribution of mouse strains at CWRU

Abstract
The Case Transgenic and Targeting Facility is the sole transgenic core serving NIH-funded
researchers in Northeast Ohio. The core has created and cryopreserved mouse genetic models
for over twenty years. These mouse models have been used by local researchers and
researchers around the world to study cancer, cystic fibrosis, neurodegeneration, viral
immunology, skeletogenesis, cardiovascular disease, and many other diseases and fundamental
biological processes. Gene editing increased the number of models that the core has been able
to create. Now more than ever, the NIH-funded researchers we serve need these strains backed
up, archived for future retrieval, or distributed to their collaborators and other scientists as
cryopreserved sperm or embryos. This application requests funding for equipment which will
modernize the core's mouse strain cryopreservation, make it more cost-efficient, increase
capacity and bring the operation in line with current best practices. The core needs this
modernization to meet the demand from local researchers, research centers, and from new
institutional research initiatives in translation of gene-directed therapies and in studies of the
microbiome.

Public health relevance
Narrative Mouse genetic models are important for fundamental and biomedical research and in the development of disease therapies. This grant application seeks funding for equipment to make the backup, archiving and distribution of cryopreserved mouse strains modern and secure, and will increase capacity to serve NIH-funded researchers in Northeast Ohio.